Neuropsychological Impairment In Schizophrenia

Over the past year we have attempted to characterize more completely the cognitive disturbances in schizophrenia. In particular we have begun work on the mechanisms accounting for failures in memory in schizophrenia. Patients' difficulties do not appear to be due to qualitative abnormalities in susceptibility to interference, encoding, or so called false memory problems. We have begun to comnputationally model the episodic memory impairments in schizophrenia in order to determine if they are due to general noise or a single stage in mnemonic processing. We have examined disorganized speech in schizophrenia using various semantic processing paradigms. In general patients have difficulties not with the size of their lexicon but rather how they access it automatically, as evidenced in priming paradigms. Thus, we have devised a battery of novel experimental tasks to assess whether schizophrenic patients show a dissociation between lexical integrity and semantic abnormality. This study utilizes patients with schizophrenia, patients with Alzheimer's disease and children to find dissociations between the size of the verbal lexicon and its organization. If this is the case then it has important implications for normal cognitive architecture. We have also found using both a nonverbal morphing task and a reaction time task that patients do not have undue difficulty with understanding what an entitiy is, it is their ability to understand the relations between things that is abnormal. We have begun work on a study which compares the integrity of the internal representation itself to the integrity of activation among representations using various types of number priming Finally, a genetic study of schizophrenia with an emphasis on intermediate phenotypes is ongoing. We are using a large battery of neurocognitive measures to characterize this "intermediate" phenotype. We base this on the rationale that patients do not inherit schizophrenia per se but a variety of susceptibilities to cognitive impairments and their attendant neurophysiologic abnormalities. We have already found that some cognitive measures yield high relative risks that are not redundant with diagnosis. These include episodic memory tasks and an N-Back working memory task with high demands for temporal encoding and information updating.Moreover, we have identified a gene (COMT) that has an impact on the N Back through dopamine signaling.